Molecular and Cellular Mechanisms in Coronary Artery Development and Anomalies

PROJECT SUMMARY
Normal coronary artery formation is essential for heart growth and function. Malformed coronary arteries are a
clinically significant birth defect that can cause life-threatening cardiac complications, including ventricular
noncompaction, myocardial ischemia, and sudden cardiac death. Yet, developmental mechanisms that drive
proper coronary artery formation are incompletely understood, which has hindered our ability to develop the
heart-specific interventions for this devastating disease. The long-term goal of this project is therefore to reveal
the molecular and cellular mechanisms underlying coronary artery development so that we may identify key
regulatory factors for developing new targeted therapies to combat this congenital condition. We have addressed
this goal during previous finding period. Our studies have shown that embryonic coronary arteries in the inner
compact myocardium are formed by ventricular endocardial cells through angiogenesis regulated by the VEGF-
NOTCH signaling. Furthermore, our studies have revealed that these embryonic coronary arteries undergo
angiogenic expansion perinatally to add the neovessels to the growing compact myocardium. However, in
contrast to the vascularization of the compact myocardium, we know little about vascularization of trabecular
myocardium which remains largely avascular until birth. We have recently identified a subpopulation of coronary
progenitor cells among ventricular endocardial cells which are committed to the coronary arteries in the
trabecular myocardium. We named these cells as the second wave coronary progenitors (SCPs) to separate
them from the first wave coronary progenitors (FCPs) for the coronary vessels at the compact myocardium.
SCPs acquire angiogenic potential earlier in embryonic development through a previously unknown endocardial
to mesenchymal transformation (EMT) long before they undergo angiogenesis later during perinatal periods to
vascularize the trabecular myocardium. In this renewal application, we propose to characterize this new
angiogenic-EMT paradigm (angioEMT) by SCPs. Our overarching hypothesis is that vascularization of trabecular
myocardium by SCPs is regulated by a “two-hit” mechanism involving sequential angioEMT and hypoxia
signaling. We plan to test this hypothesis in three Specific Aims. Aim 1 will characterize SCPs by distinguishing
them from FCPs using a lineage-based single cell RNA-sequencing (scRNA-seq) analysis and a modified
functional angioEMT assay. Aim 2 will define the angioEMT signaling in the early fate decision by SCPs using
genetic loss-of-function approaches investigating the TGFb signaling. Aim 3 will decipher the angiogenic
signaling in the later angiogenic activation of SCPs focusing on VEGFA-VEGFR3 and DLL4-NOTCH1 signaling.
Vascularization of trabecular myocardium as well as trabecular compaction in the individual nulls will be
examined by histology, immunostaining, and RNAscope in situ hybridization. The changes in the SCP lineages
will be determined by scRNA-seq analysis, whereas the key factors underlying the two-hit angioEMT process
will be identified through gene network analysis. By completing these aims, we expect to provide new
mechanistic insights into coronary artery development that inform developmental pathogenesis of coronary
artery anomalies and ventricular noncompaction.

Public health relevance
NARRATIVE Coronary artery anomalies are a congenital disease severely affecting heart growth and function. This research project studies the developmental mechanisms that control the proper formation of the coronary arteries, with a goal to identify key regulatory factors that may be used for developing new therapies to combat this devastating disease.